TCR signaling regulated T cell exhaustion in response to chronic viral infection

Summary
Although it is becoming increasingly clear that CD8+ T cells responding to chronic infection are phenotypically
and functionally diverse, little is known about how to overcome T cell exhaustion to treat infectious diseases.
Using single cell RNA sequencing (scRNA-seq), the investigator’s team has confirmed the presence of
previously identified TCF-1hi progenitor and PD-1hi exhausted T subsets. Surprisingly, they also found a CX3CR1+
effector subset at the late phase of chronic infection. More importantly, they have shown that CX3CR1+ effector
cell formation is critically dependent on IL-21-producing CD4+ helper T cells. The discovery of this potent antiviral
effector subset provides new opportunities for therapeutic interventions to treat infectious diseases. To better
understand the genesis of CX3CR1+ effector cells, the investigator’s team proposes to use the newly developed
technology of paired single-cell RNA and TCR sequencing (scTCR-seq) to “lineage trace” back to the ancestors
(progenitors) of effector and exhausted cells. Their preliminary data suggest that TCR signaling strengths
positively correlate with exhausted T cell subset differentiation, but negatively correlate with effector T cell
differentiation. In parallel, they also provide evidence that CX3CR1+ effector cell formation depends on cross-
presenting dendritic cells (DCs), especially Batf3+ XCR1+ cDC1s. These cDC1 cells are likely subjected to CD40-
mediated CD4 helper T cell licensing, which is unexpected in the context of persistent infection and possibly
occurs within specialized cellular structures. Taken together, the investigator hypothesizes that progenitor CD8+
T cells need to be primed and activated by the cDC1s again at the late phase of chronic infection to enter into a
proliferative burst as a transitory differentiation state, and then bifurcate into two terminally differentiated subsets:
CX3CR1+ effector and PD-1hi exhausted CD8+ T cells. Mechanistically, CD4+ T cells need to provide signals to
license DCs for their antigen-presentation, and TCR signaling strength dictates the threshold of progenitor cell
activation and influences the effector versus exhausted cell fate choice. Harnessing this knowledge, they intend
to alter the course of T cell differentiation by changing TCR signaling strength through identification and validation
of TCR signaling regulators (TSRs) that can be exploited to favor the formation of CX3CR1+ effector T cells for
improved viral control. The investigator’s team will test these hypotheses in the following three aims. First, they
will use paired scRNA- and scTCR- seq and associated computational tools and biological validations to
delineate virus-specific CD8+ T cell differentiation trajectories and dissect how TCR signaling strength affects
cell fate decisions. Second, they will use genetic models to delineate the mechanisms by which DCs are licensed
by CD4+ helper T cells for CD8+ T cell priming and differentiation. Third, they will employ high-throughput targeted
CRISPR screen and gene editing to test if manipulating TCR signaling strength can redirect CD8+ T cells toward
effector differentiation and overcome exhaustion to treat chronic infection and cancer.

Public health relevance
Narrative Successful control of chronic viruses, such as HIV and HCV, greatly depends on vigorous and well-coordinated CD4+ and CD8+ T cell responses. This study aims to identify cellular and molecular mechanisms, as well as rational designs of therapeutics, that favor the formation and function of effector CD8+ T cells. The goal is to help CD8+ T cells remain effective and avoid exhaustion, which is essential for treating chronic infections and cancer.